Earliest predictors of language outcomes in high-risk infants

One in every nine babies in the US is born preterm. Speech, language and hearing disorders
(SLD) are among the most prevalent neurodevelopmental disorders in children, especially
among very preterm survivors. About 40% of very preterm infants (≤32 weeks gestational age)
develop speech-language disorders while 10% have permanent hearing loss, increasing the
impact on communication difficulties. Currently, it is not possible to accurately predict in the first
several years of life which children will develop speech-language disorders, and speech-
language therapy is the most delayed of any intervention provided to preterm infants. Such an
advance would facilitate early intervention and research therapies during critical windows of
optimal neuroplasticity. Our central hypothesis is that prediction of speech-language disorders is
possible by 3 m corrected age (CA) with combined innovative measures of structural and
functional brain connectivity with magnetic resonance imaging, evoked response measures of
speech processing, and novel, sensitized hearing measures. Primary aims of this supplement
are: Aim 1. Compare verbal, nonverbal, and social communication in full-term and preterm
toddlers. Aim 2. Compare hearing sensitivity (cABR and DPOAE) in full-term and preterm
infants, and behavioral audiometry in full-term and preterm toddlers. Compare rsfEEG and MMR
in full-term and preterm infants.This study will enroll healthy, fullterm children to collect
comprehensive hearing and neurophysiologic measures at 3 months, and language and hearing
assessment at 2 years CA for comparison to matched preterm children.

Public health relevance
Speech-language disorders occur in 40% of very preterm infants, while 10% have permanent hearing loss. Neonatal hearing screening and cochlear implantation within the first few months have demonstrated the extreme plasticity of the developing infant brain, but speech-language disorders are typically not detected or treated before 3 years of age. The goal of this supplement is to use advanced measures of brain connectivity, sensitized hearing assessment, and language at birth to predict infants at risk for speech-language disorders so they can start receiving intervention within the critical first year.